Leadership, Planning and Evaluation

LEADERSHIP, PLANNING AND EVALUATION PROJECT SUMMARY
The Mayo Clinic Cancer Center (MCCC) has a robust planning and evaluation process in place across all of its
sites. Dr. Diasio as Director leads a strong senior leadership team with each team member having a well-
defined role and responsibilities. These include: Dr. Robert Smallridge as Deputy Director for Mayo Clinic in
Florida (MCF), Dr. Aleksandar Sekulic as Deputy Director for Mayo Clinic in Arizona (MCA), Dr. Daniel
Billadeau as Deputy Director for Basic Science, Dr. Steven Alberts as Deputy Director for Clinical Research,
Dr. Gloria Petersen as Deputy Director for Population Sciences, Ms. Jane Welter as Deputy Director for
Administration, Dr. Thomas Witzig as Associate Director for Translational Research, Dr. Aminah Jatoi as
Associate Director for Research Education, and Dr. Carmen Radecki-Breitkopf as Associate Director for
Cancer Disparities and Community Outreach. Members of the senior leadership team meet twice monthly;
once as the senior most leadership committee made up of Director and Deputy Directors, the MCCC Executive
Committee, and once as a larger group with the Associate Directors, the MCCC Research Committee. The
MCCC Research Committee receives input from the Internal Scientific Advisory Committee and the Clinical
Research Committee. Dr. Diasio and the Center receive advisory input internally from the Mayo Clinic
Research Committee, directed by the Executive Dean for Research and externally from the External Advisory
Committee made up of directors and senior leaders from other centers who provide expertise in the various
program areas. The center also benefits from expertise provided by a Community Advisory Board made up of
patients, family members of patients, and advocates in various cancer areas. Since the last competitive
renewal, MCCC has conducted strategic planning that has resulted in a number of new research directions that
have been undertaken leading to a number of new directions and accomplishments.